Role of Epithelial Chemokines in Kidney Injury-Molecule-1 Induced Renal Fibrosis

DESCRIPTION (provided by applicant): A link between acute kidney injury (AKI) and the development of chronic kidney disease (CKD) is increasingly appreciated, but the molecular mechanisms remain obscure. Kidney Injury Molecule-1 (Kim-1) is a phosphatidylserine receptor upregulated only on injured epithelial cells of the kidney where it clears the tubular lumen of apoptotic and necrotic cells after injury. The applicant's K08 grant proposed to investigate the possible contribution of Kim-1 to the development of renal fibrosis with prolonged Kim-1 expression. To do so, the applicant created a transgenic mouse model for the conditional expression of Kim-1 exclusively on renal epithelia. Transgenic mice were healthy and renal histology was normal at birth. Beginning at 4 weeks, a spontaneous and progressive mononuclear infiltrate was observed in Kim-1 expressing kidneys consisting of CD3+ lymphocytes, as well as dendritic cells and macrophages. Older mice developed progressive inflammatory cell infiltration and progressive proteinuria, anemia, renal failure, interstitial fibrosis and death from renal failure by 19 weeks. Kim-1 expression in very young mice was associated with strongly elevated pro-inflammatory chemokine and cytokine expression despite normal tubule histology, suggesting that the mechanism behind this fibrotic response is the Kim-1 dependent recruitment of pro-inflammatory cells to the kidney. These results link epithelial injury, the innate immune system and chronic inflammation and indicate that Kim-1 is not simply a biomarker of disease in humans but is instead a therapeutic target. To probe the mechanism of these clinically relevant findings, we propose in this R03 application to test the hypothesis that Kim-1 expression drives chronic renal fibrosis by recruiting T cells and macrophages to the kidney through epithelial cell production of the chemokines CXCL-1, CXCL-10 and macrophage chemoattract protein-1 (MCP-1). We will test this hypothesis with the following two specific aims: (1) Do Kim-1 positive renal epithelial cells in Kim-1 transgenic mice show evidence of expression of CXCL-1, CXCL-10 and MCP-1? We will use a combination of fluorescence activated cell sorting (FACS), immunofluorescence microscopy and primary epithelial cell culture to assess activation of these pro-inflammatory signals in both Kim-1 transgenic and in wild-type mice subjected to renal injury to induce endogenous Kim-1 protein. (2) Does expression of Kim-1 and/or activation of Kim-1 by phagocytosis trigger acute activation of the NF-kB pathway, resulting in expression of pro-inflammatory signals? We will use two inducible Kim-1 cell culture models and trigger Kim-1 ligation to assess NFkB pathway activation using an ELISA-based assay, western blotting and NFkB transcriptional activity. PUBLIC HEALTH RELEVANCE: The increasing prevalence of chronic kidney disease in our aging population represents an enormous health burden. Because the final common pathway for most chronic nephropathies is renal fibrosis, therapies that reverse or even slow fibrosis would have tremendous clinical impact. These studies will explore the molecular mechanism by which Kim-1 recruits inflammatory cells to the injured kidney and thereby identify a novel pathway that may serve as an important therapeutic target in treating renal fibrosis. The proposed studies are therefore of great public health interest.

Public health relevance
Project Narrative: This proposal describes a 2 year program for the continued development and transition to full independence for a career in academic nephrology. The principal investigator is in his third year of funding through the K08 mechanism and has started his own laboratory one year ago. The plan will promote full independence by supporting salary and technician support to finish a highly interesting and clinically relevant basic science project. Research will continue to focus on Kidney Injury Molecule-1 (Kim-1), a membrane protein that is strongly induced in proximal tubular renal epithelium after kidney injury. Kim-1 promotes a dedifferentiated cell phenotype in vitro, and the PI created a transgenic model for conditional overexpression of Kim-1 in kidney epithelial cells. This mouse develops spontaneous renal failure and renal fibrosis associated with an inflammatory infiltrate. The specific aims of this proposal include: 1) Determine whether Kim-1 positive epithelial cells in transgenic mice express activated NF-kB as well as the pro-inflammatory chemokines CXCL4 and CXCL10, and 2) Determine whether Kim-1 expression or activation in vitro triggers NF-kB activation and expression of pro-inflammatory cytokines and chemokines. The increasing prevalence of chronic kidney disease in our aging population represents an enormous health burden. Because the final common pathway for most chronic nephropathies is renal fibrosis, therapies that reverse or even slow fibrosis would have tremendous clinical impact. These studies will explore the molecular mechanism by which Kim-1 recruits inflammatory cells to the injured kidney and thereby identify a novel pathway that may serve as an important therapeutic target in treating renal fibrosis. The proposed studies are therefore of great public health interest.